NEUROENDOCRINOLOGY OF ALCOHOLISM

Study in abstinent men of the frequency and nature of abnormalities of both the basal diurnal rhythm and the response to the appropriate hypothalamic releasing hormone of the hypothalamic-pituitary-adrenal and hypothalamic-pituitary-thyroid axes.